Metabolic Regulation by Microglial Inflammatory Signaling

Project Summary
Diabetes and obesity are interconnected diseases with significant public health ramifications. Overnutrition
triggers immune cell activation in the brain that promotes weight gain and was therefore presumed to worsen
glucose tolerance. On the contrary, we recently discovered a marked dissociation between the regulation of
energy balance and glucose homeostasis by microglia. Mice with microglia-specific deletion of inflammatory
signaling are protected from diet-induced obesity but show glycemic dysregulation when compared with
weight-matched controls. Similarly, mice with impaired prostaglandin signaling in microglia show unaltered
inflammatory responses but less diet-induced phagocytic activity, resulting in leaner mice but without a glucose
benefit. In contrast, genetically increasing microglial inflammatory signaling triggers weight gain even on a
chow diet but nevertheless improves glucose tolerance relative to the leaner control mice. Thus, there is a
bidirectional relationship between microglial activation and glucose tolerance.
To explore mechanism, we developed a mouse model with the Gq-coupled DREADD receptor hM3D
expressed in microglia. Chemogenetic microglial activation evokes an acute improvement in glucose tolerance
even in the setting of HFD feeding. The mechanism involves a TNF-dependent pathway by which glucose-
triggered neuronal activity is increased in melanocortin neurons, ultimately leading to parasympathetic
enhancement of insulin secretion. Importantly, Gi-coupled DREADD activation worsens glucose tolerance,
providing a rationale to test Gi-GPCR antagonists for anti-diabetic efficacy. Our preliminary data show that
central blockade of the P2Y12 receptor, a major microglia-specific Gi-GPCR, markedly improves glucose
tolerance, supporting the viability of this approach. In this proposal, we will further explore the therapeutic
potential of this system in preclinical models of diabetes and explore mechanisms contributing to the glycemic
benefits. In Aim 1, we will perform the first studies measuring neuronal activity in response to a direct cell-
specific manipulation of microglial activation state. Specifically, we will use electrophysiology and fiber
photometry to determine how microglia modulate melanocortin neuron glucose sensing and electrical activity.
In Aim 2, we will assess the natural history of microglial state changes during the development of DIO and
DM2 along with the impact of chronic microglial activation. Further, we will assess the contribution of microglial
phagocytic capacity to metabolic regulation using tools related to the key regulatory protein MerTK. Finally, we
will test the participation of the P2Y12 receptor in the regulation of glucose homeostasis by microglia.
Together, these studies will help test the hypothesis that microglial inflammatory signaling and phagocytic
capacity function to offset obesity-associated glucose intolerance via alterations to hypothalamic glucose
sensing, a mechanism that can be harnessed to improve glycemia in the setting of T2D.

Public health relevance
NARRATIVE Diabetes is highly prevalent and a major cause of morbidity and mortality worldwide. New evidence shows that immune cells in the brain called microglia contribute to glucose regulation through interactions with neighboring neurons. This project investigates neuron-microglia relationships and explores the potential of microglial cells as targets for diabetes treatments.